Epigenetic regulation of stress-potentiated ethanol drinking

Epigenetic Regulation of Stress-Potentiated Ethanol Drinking
PROJECT SUMMARY/ABSTRACT
A common mechanism that regulates both stress-sensitivity and alcohol use is epigenetic regulation of gene
transcription. Of particular importance in substance-use disorders is G9a, a histone methyltransferase implicated
in models of alcohol use disorder (AUD). G9a in the nucleus accumbens (NAc) regulates drinking, but its
mechanisms are unknown. The long-term goal of this project is to elucidate the mechanisms that can lead to
stress-potentiated drinking and to discover methods to block or reverse these changes. Because the dynorphin
system plays a prominent role in stress and ethanol-related behaviors, and dynorphin is present in a major subset
of NAc neurons, Aim 1 will test the hypothesis that NAc G9a’s effects on stress-potentiated ethanol drinking are
mediated through dynorphin-positive neurons (NAcDyn+). This hypothesis will be tested by using a novel Cre-
dependent shRNA viral vector and a novel Cre-dependent G9a over-expression viral vector in both dynorphin-
Cre mice and enkephalin-Cre mice. Specifically, G9a will be knocked down or overexpressed in these NAc
neuronal subsets, and the effects of G9a will be tested on two different forms of stress-potentiated drinking. We
will also examine the NAc subregions involved in G9a’s effects. Next, Aim 2 will test the hypothesis that the
mechanism underlying G9a’s effects on stress-potentiated ethanol drinking involve NAc intrinsic excitability by
altering the expression of a specific potassium (K+) channel subunit. The hypothesis for Aim 2 is that the effects
of G9a on this K+ channel subunit reduces stress-potentiated drinking. We will directly test G9a’s ability to
regulate this K+ channel subunit with a CRISPR-fused G9a, and we will test G9a’s effects on transcription and
chromatin state using single nuclei multiomics. Finally, Aim 3 will test the hypothesis that the effects of NAc G9a
on stress-potentiated ethanol drinking are mediated via changes in activity in the bed nucleus of the stria
terminalis (BNST). Based on preliminary c-Fos data, Aim 3 will test the hypothesis that endogenous NAc G9a
increases stress-potentiated drinking by decreasing the activity of the BNST. Studies in this aim will first
determine which BNST subregions are influenced by alcohol, stress, and NAc G9a using immunolabeling-
enabled three-dimensional imaging of solvent-cleared organs (iDISCO). Next, the project will determine if these
c-Fos+ BNST neurons are sufficient to modulate stress-potentiated ethanol drinking by using Targeted
Recombination in Active Population (c-Fos-TRAP) mice combined with Cre-dependent expression of designer
receptors exclusively activated by designer drugs (DREADDs) in BNST ensembles. Finally, this Aim will directly
test the NAc to BNST pathway with a combination of a retrograde virus that expresses cre and a cre-dependent
shG9a virus. The central hypothesis is that NAc G9a increases stress-potentiated drinking through changes in
gene expression that decrease the excitability of NAcDyn+ neurons and reduces activity of the bed nucleus of the
stria terminalis (BNST). These studies will use a comprehensive approach to determine the effects of the
epigenetic regulator G9a and will greatly enhance understanding of how stress potentiates alcohol drinking.

Public health relevance
PROJECT NARRATIVE Stress perpetuates the cycle of excessive alcohol drinking and contributes to the transition to an alcohol use disorder (AUD). Though stress increases drinking, treatments that target stress-potentiated alcohol use are lacking due to an incomplete understanding of the underlying mechanisms. The long-term goal of this project is to elucidate the epigenetic mechanisms that can lead to stress-potentiated drinking as this could lead to future treatments for patients suffering from AUD.